Administrative Core

Abstract: The Administrative Core (AC) will support the Program Director of the Center for
Translational Viral Oncology (CTVO) during its Phase 2 operation by providing the overall
planning and coordination of the mentoring and research for the selected group of Junior Principle
Investigators (PJIs). The AC will be responsible for managing the day-to-day operations of the
Center, organizing advisory committee meetings, facilitating JPIs privileged access to research
core facilities, evaluating new pilots and research projects, and promoting interdisciplinary
interactions. This will ensure an appropriate career development for JPIs who have a strong
interest in utilizing their most important research findings for the development of new preventive
and/or therapeutic modalities against virus-associated cancers. There are three major factors
which make the CTVO highly competitive and unique: 1) Access to a unique minority patient
population that is disproportionally affected by virus-induced cancers; 2) Experienced basic
research and clinical scientists who are dedicated to the study of viral cancers and are highly
motivated to serve as mentors and advisors in CTVO; and 3) State-of-the-art Research Core
Facilities. The AC is designed specifically to facilitate each of these crucial components through
the following specific aims: Aim 1: Provide scientific leadership and administrative structure for
coordinating thematic research on viruses and cancer across participating institutions, including
peer review from internal and external advisors, and for integration of CTVO with other programs
dedicated to research, patient care, teaching, and community engagement. Aim 2: Support the
development of highly competitive Principal Junior Investigators (JPIs) through mentoring and
career development plans within the CTVO and their Academic Departments. Aim 3: Promote
the development, sustainability, and effective utilization of research core facilities, novel scientific
techniques and resources while instilling an awareness and sensitivity to gender, economic and
ethnic inclusiveness, and equity in all activities. The participating institutions include Louisiana
State University Health Sciences Center (LSUHSC), New Orleans; LSUHSC, Baton Rouge;
LSUHSC, Shreveport; and Tulane University Medical Center (TUMC), which are responsible for
the majority of patient care, research, and scientific training in the region. These institutions
support state-of-the-art core facilities, tumor registries, electronic medical records, clinical trial
units and bioinformatics. We have engaged these valuable institutional resources and have
selected outstanding basic research and clinical mentors to create this highly motivating and
competitive research environment for COBRE-supported JPI candidates.